Fine particulate matter exposure and small cerebrovascular inflammation

Abstract
Dementia is a major challenge to public health without effective therapy. Ambient fine particulate matter (PM)
exposure significantly increases the risk for cognitive dysfunction and dementia with the mechanism(s) largely
unknown. Animal studies have revealed that PM exposure significantly impairs cognition with decreased
learning capability without clearly defined mechanisms. Small cerebrovascular diseases significantly contribute
to vascular cognitive impairment and dementia. Preliminary studies showed that PM exposure resulted in
significant small cerebrovascular inflammation with excessive reactive oxygen species (ROS) production in
association with significant increases in serum TNF-α, IL-6, and IL-1β in male wildtype (WT) C57BL/6 mice.
While PM exposure also induced significant cerebral vascular inflammation in female WT C57BL/6 mice, only
IL-6 and IL-1β, not TNF-α, were significantly increased. Treatment of male WT mice with TNF-α, but not IL-6
or IL-1β, induced significant inflammation in small cerebral vasculature, and no inflammation was observed in
small cerebral vessels in male TNF-α deficient mice with PM exposure. In contrast, treatment of female WT
mice with IL-6 triggered a significant inflammation in cerebral vasculature, and no inflammation was present in
cerebral vessels in female IL-6 deficient mice with PM exposure. Initial data also demonstrated that PM
exposure significantly impaired the memory and learning capability in male mice that were effectively
prevented with TNF-α deficiency (either with specific antibody treatment or TNF-α knockout). Thus, the present
project was proposed to test the novel hypothesis that “PM exposure induces significant small
cerebrovascular inflammation due to increased production of TNF-α in males and IL-6 in females,
leading to cognitive dysfunction”. There are three specific aims: 1) to test the hypothesis that TNF-α
mediates the effect of PM exposure on small cerebrovascular inflammation in males; 2) to test the hypothesis
that IL-6 plays a critical role in PM exposure-induced small cerebrovascular inflammation in females; and 3) to
investigate the mechanisms for sex differences in PM exposure-induced productions of TNF-α and IL-6. Aging
WT C57BL/6 mice (both male and female) will be exposed to PM. ROS production and cerebral microvascular
inflammation will be quantitatively evaluated at different time points after PM exposure. Brain MRI imaging will
be performed to evaluate structural changes at baseline, 1 week (acute effect), and 2 months (chronic effect)
after PM exposure. Mouse learning and memory capability will be longitudinally evaluated at baseline, 2, 4,
and 8 weeks after PM exposure. Studies will also be conducted using male TNF-α deficient mice and female
IL-6 receptor deficient mice, as well as macrophage depletion mouse model (both male and female) to define
the mechanism(s). The data from the present project will provide important and novel information on the
mechanisms for the development and progression of dementia in patients with PM exposure and help explore
new approaches to preventing and treating dementia related to PM exposure.

Public health relevance
Project Narrative Dementia is a major challenge to public health without effective therapies available. Ambient fine particulate matter (PM) is the key component of air pollution, and PM exposure significantly increases the risk for cognitive dysfunction and dementia with the mechanisms largely undefined. The present study is proposed to determine how PM exposure results in significant cognitive dysfunction and dementia in males and females and help explore new and effective approaches to preventing and treating dementia related to PM exposure.